O-GLCNAC HOMEOSTASIS REGULATES MITOCHONDRIAL FUNCTION IN ALZHEIMER'S DISEASE

Currently, 5.4 million Americans are suffering from Alzheimer’s disease (AD), which is the only major disease
lacking good prevention methods, treatments, or a cure. Recent evidence suggests that age related
impairment of mitochondrial function and increased reactive oxygen species (ROS) production contribute to
cellular damage and AD progression. The object of this proposal is to understand the affects of O-GlcNAcylation on mitochondrial function and the development of AD. O-GlcNAc is categorized by the addition
of a single O-linked β-N-acetyl-D-glucosamine moiety to serine/threonine amino acids of nuclear and
cytoplasmic proteins. This modification is responsive to extracellular signals such hormones, nutrients, and
environmental cues and is involved in regulating numerous cellular functions such as the cell cycle, stress
response, transcription, and translation. The enzymes responsible for processing the modification are O-GlcNAc transferase (OGT), which adds the modification, and O-GlcNAcase (OGA), which removes the
modification. Importantly, changes in O-GlcNAcylation alter mitochondrial function. Cells actively maintain
homeostatic levels in O-GlcNAc, and cells will alter the expression of OGT and OGA to modulate O-GlcNAcylation due to changes in the environment. We contend that O-GlcNAcylation is disrupted in chronic
metabolic disease, which exacerbates the decline in mitochondrial function. We have demonstrated that over-expression of OGT or OGA causes large changes in protein expression of electron transport chain and Krebs
cycle proteins, respiration is impaired, and mitochondrial morphology is disrupted. These data suggest that
alterations to O-GlcNAc homeostasis would affect mitochondrial function exacerbating AD. In the current
proposal, we will determine the mechanisms as to how O-GlcNAcylation regulates cellular function. First, we
will identify changes to the transcriptome, proteome, and O-GlcNAcome in mouse models of AD or after loss of
OGT. We will then determine how disrupted O-GlcNAc homeostasis affects electron transport chain function
and metabolic gene expression. We will address the effect of OGA inhibitors on ameliorating mitochondrial
dysfunction in AD mouse models. Furthermore, we will explore how O-GlcNAcylation influences mitochondrial
anti-oxidant response. Our preliminary data shows that alterations in O-GlcNAc induce changes in anti-oxidant
response and NRF2 activity, a critical transcription factor controlling the transcription of anti-oxidant genes. We
will ascertain the mechanistic role of O-GlcNAc in regulating NRF2 transcriptional activity and protein
interactions. Finally, we will use AD patient samples to identify the potential to use of O-GlcNAc, OGT or OGA
as AD biomarkers. These studies will provide new mechanistic details into how O-GlcNAcylation affects
mitochondrial function, how O-GlcNAc influences anti-oxidant response, NRF2 function, and will provide new
pathways for clinical intervention of AD.

Public health relevance
O-GlcNAcylation is the attachment of a single O-linked β-N-acetyl-D-glucosamine moiety to serine/threonine residues of nuclear, mitochondrial, and cytoplasmic proteins; as such, this modification regulates numerous cellular process such transcription, translation, cell cycle, and signaling. Importantly, O-GlcNAc is a critical regulator of mitochondrial function and disruption in the normal homeostatic levels of O-GlcNAc impairs respiration. This proposal will develop a new understanding of how O-GlcNAc regulates mitochondrial respiration and anti-oxidant response in the context of Alzheimer’s disease.